CSHL 2024 Conference on Neurodegenerative Diseases: Biology & Therapeutics

ABSTRACT
Neurodegenerative Diseases: Biology & Therapeutics
December 4 - December 7, 2024
This proposal seeks support for the biennial conference on Neurodegenerative Diseases: Biology
& Therapeutics, from December 4 – December 7, 2024 at Cold Spring Harbor Laboratory (CSHL).
The meeting brings together scientists who investigate both basic and translational aspects of
neurodegenerative disorders such as Alzheimer’s disease, Parkinson’s disease, and amyotrophic
lateral sclerosis. For many of these disorders, the molecular pathways of the disease processes
remain unclear and thus few biomarkers have been identified. For other disorders, existing
treatments are designed primarily to provide relief from symptoms without addressing the biology
underlying degenerative processes. Translational research is therefore needed to develop and
validate novel diagnostic strategies as well as new therapeutics that might halt or stem disease
progression, rather than simply alleviate symptoms. The conference will advance knowledge in
neurodegeneration by providing a forum where scientists from distinct laboratories and
institutions, both academic and industry, can exchange findings, ideas, and seek collaborations.
It will include sessions on convergent and divergent pathways in neurodegenerative diseases,
glial biology, immune system, therapeutic strategies, APOE and lipid metabolism, cell biology,
and biomarkers and structural studies. For human studies seeking new treatments for
neurodegeneration to be informative, it is essential for scientists who research different aspects
of those treatments to meet regularly in a setting like CSHL to exchange data and ideas. The
2024 CSHL meeting on Neurodegenerative Diseases: Biology & Therapeutics will build on the
successes of prior CSHL meetings to assemble an international gathering of top scientists from
academia and the biopharmaceutical industry, discuss new developments in the field, and
catalyze innovative research collaborations, all of which will ultimately accelerate the pace of
discovery.

Public health relevance
PROJECT NARRATIVE Neurodegenerative Diseases: Biology & Therapeutics December 4 - December 7, 2024 Neurodegenerative diseases exert a staggering cost to governments and societies, and thus have become an urgent concern to public health worldwide. The cost of Alzheimer’s disease in the U.S. alone in 2023 has exceeded a quarter trillion dollars. Unfortunately, detailed understanding of the disease processes critical for effective therapeutic interventions for many such disorders remains sketchy. Thus, basic research of the disease process is needed to develop novel diagnostic strategies and new therapeutics that might halt or stem disease progression. The Cold Spring Harbor Laboratory conference on Neurodegenerative Diseases: Biology & Therapeutics will advance knowledge in the field by bringing together top scientists with expertise in disparate aspects of neurodegeneration in an excellent venue that will provide an ideal forum for catalyzing scientific interactions and collaborations to accelerate discoveries of effective therapeutics for the treatments of neurodegenerative diseases.